Great Lakes NARCH 11

Abstract: GLNARCH OVERALL
This Great Lakes Native American Research Centers for Health (GLNARCH) application aligns
established partnerships to generate a network of resources for AI/AN programs as well as support ongoing
successful initiatives. We have identified opportunities to establish synergistic education, training, and research
within the Indian Health Service Bemidji Region with increased focus on including Tribal Colleges and
Universities (TCU). This application proposes an unprecedented endeavor to engage AI/AN populations in
cultivating an indigenized (culturally responsive) research and training agenda. This agenda will follow the
common AI/AN cultural theme of holistic health and wellness connected to the land and the unique natural
resources of the Great Lakes region. The Student Career Enhancement Project (SCEP) proposes exciting
opportunities to expose AI/AN students to remote learning, thereby connecting them in an indigenous styled
network whilst also preparing them for 21st century education. The Capacity Building Project is responsive to
recent experiences and evaluation reports to seek even better research networks and resource sharing within
the GLNARCH service area, which is geographically broad and underfunded. The Capacity Building Project
proposes unique initiatives to better engage TCUs via the established and successful Native American
Environmental Health Research (NEHR) network. Leveraging modern technology will increase both research
and training capacity in the tribal community and academic spheres. The proposed team has successfully
implemented over 16 years of successful and impactful GLNARCH programming. They possess the necessary
skills, institutional environment, and connections to execute these aims.

Public health relevance
NARRATIVE: GLNARCH OVERALL This Great Lakes Native American Research Centers for Health (GLNARCH) application will pursue exciting opportunities to improve education, training, and research within the Indian Health Service Bemidji Region with increased focus on including Tribal Colleges and Universities (TCU). The Student Career Enhancement Project (SCEP) proposes important activities to expose AI/AN students to remote learning. The Capacity Building Project proposes unique initiatives to better engage TCUs via the established and successful Native American Environmental Health Research (NEHR) network.